Investigating Social Vulnerability, Environmental Exposures, and Alzheimer's Disease Disparities in the United States National Health and Nutrition Examination Survey (NHANES)

PROJECT SUMMARY ABSTRACT
Alzheimer's Disease and Related Dementias (ADRD) pose a significant public health challenge, particularly
among socially vulnerable populations. This diversity supplement, led by Laura Arboleda Merino, a doctoral
candidate in Epidemiological Sciences at the University of Michigan, aims to investigate the role of social
vulnerability as an independent risk factor for ADRD incidence and as a susceptibility factor in the association
between heavy metals (lead and cadmium) and ADRD. Under the mentorship of Drs. Bakulski and Park and
supported by a distinguished mentorship committee including Drs. Bhramar Mukherjee, Henry Paulson, Roger
Albin, and Hiroko Dodge, the project will develop and validate a Social Vulnerability Index (SVI) tailored to aging
populations. Using advanced statistical methodologies such as Factor Analysis, Principal Component Analysis
(PCA), and multivariate imputation (MICE) in R software, Ms. Arboleda Merino will explore disparities in
healthcare access and outcomes among vulnerable communities, aiming to inform targeted interventions.
Ms. Arboleda Merino’s training will encompass three key areas critical for her career development: deepening
her expertise in ADRD research through specialized programs and conferences; advancing her statistical
analysis skills to construct the SVI; and enhancing her research communication and career development through
manuscript preparation, peer feedback, presentation of findings, and participation in faculty development
programs and workshops, all aimed at preparing her for a successful transition to an independent research
career.
This comprehensive approach seeks to advance our understanding of ADRD within vulnerable populations and
prepares Ms. Arboleda Merino for an impactful career in epidemiology and academia. By bridging research with
practice, this project aims to contribute to public health initiatives that address health disparities and improve
outcomes for aging populations affected by ADRD.

Public health relevance
PROJECT NARRATIVE Relevant to the parent grant, Laura Arboleda Merino, a PhD student in the University of Michigan Epidemiology Department, aims to explore how social vulnerability shapes the association between neurotoxic heavy metal exposures (e.g., lead and cadmium) and Alzheimer's disease and related dementias (ADRD) among older adults using NHANES and Medicare data. Her study will develop a Social Vulnerability Index (SVI) and apply advanced statistical methods to uncover these intricate relationships, informing targeted interventions and policies to mitigate ADRD disparities in vulnerable populations. Through this research, Ms. Arboleda Merino will gain expertise in ADRD research, statistical analysis, and effective research communication, positioning her for a future career as an independent researcher dedicated to improving public health outcomes.